Biostatistics and Informatics Core

PROJECT SUMMARY (See instructions); The goals of CORE C are to support and promote high quality research by assisting the Project Leaders in study design, data collection and management, quality control, data storage and retrieval, and data analysis of all studies. A key component of this Core will be to conduct statistical analysis to determine the reliability and validity of our measures and methods. In addition, this Core will help to create a data matrix so that data files can be merged across studies, a biorepository can be maintained, and data sharing can occur with investigators inside and outside of the Project investigators.

Public health relevance
RELEVANCE (See instructions): This Core will serve all Projects and Core B to provide database development, data management and data analyses.